Cancer Prevention and Control

The Cancer Prevention and Control (CPC) Program of the Tisch Cancer Institute (TCI) is highly aligned with the TCI guiding principles of discovery, translation, education, engagement, & access. CPC is comprised of 42 members spanning 16 Departments and Divisions at the Icahn School of Medicine at Mount Sinai who conduct research within the following themes: 1) Risk Factor Evaluation and Mitigation, 2) Cancer Early Detection and Screening, and 3) Cancer Healthcare Delivery. The three aims of the CPC Program span across the entire cancer continuum from cancer risk factors to screening, diagnosis, and treatment to survivorship and end-of-life issues. Since the prior submission, program members have been successful in obtaining competitive research grants from NCI (18 awards, 46% of current peer reviewed portfolio of $9.0M), other NIH Institutes (22%), and other peer-reviewed institutions (32%). Current NCI direct cost funding is $4.4M compared to $1.5M reported in 2020, representing a 190% increase. In addition, over the past funding period, CPC members authored 553 publications. Of these, 19% were in high-impact journals and 23.7% represent intra-programmatic collaborations, 17% inter-programmatic collaborations, and 47% include a collaboration with another NCI designated Cancer Center. Publications by CPC members appeared in several high-impact journals such as BMJ, Cell, Cancer, Cancer Cell, Nature, Nature Medicine, The Lancet Oncology, JAMA, JNCI, JCO and Annals of Internal Medicine. CPC has 23 multi-PI grants including 12 inter-institutional, 2 inter-programmatic, 5 intra-programmatic and 5 with other Mount Sinai faculty, reflecting strong collaborations through local, national and international networking.

Notably, the CPC program research priorities are based on incidence and mortality data associated with the catchment area of TCI, which includes the five boroughs of NYC, with disparities as an overarching focus that cut across all three of CPC’s aims. The aims are designed with the main objective of favoring intra-and inter-programmatic interactions, as well as working collaboratively with the Community Outreach and Engagement (COE) and CRTEC cores to enhance the impact of CPC research on our greater community as well as for our trainees. The Program Directors have successfully facilitated collaborations across programs through a series of activities, such as monthly inter-programmatic meetings, participation of CPC members to the TCI nodal meetings, as well as one-to-one matching of CPC members with members of other programs working on similar topics/cancer sites. CPC is poised to continue supporting and encouraging new collaborative grants and papers, MPI/P01 grant initiatives and highlighting our members’ outstanding scientific contributions with a clear impact on health policy and cancer prevention and control outcomes.